Using Ae. aegypti as a model to understand the genomic basis of rapid and repeated evolution

PROJECT SUMMARY
How fast can populations adapt to inhabit a different ecological niche or to keep track with a changing
environment? Recent studies in systems as diverse as Galapagos finches, Drosophila melanogaster, and
sticklebacks suggest that adaptation can be very fast if adaptive genetic variation is available and the genomic
architectures of adaptative traits facilitate a coordinated response to selection – especially if adaptive alleles
are grouped together in compact architectures or kept in linkage disequilibrium within chromosomal inversions.
But it has been very difficult to link fitness in natural systems, spatial and temporal patterns of allele frequency
change, and an understanding of the genomic basis of specific adaptive traits. Aedes aegypti provides a
remarkably tractable system in which to answer these questions. In this species, a human-specialist form
evolved from a generalist ancestor within the last 5000 years, likely in West Africa. This transition was
accompanied by several well-characterized changes in important traits across their lifecycle, from behavior, to
life history, to physiology. This species is easy to collect and study in the field, easy to work with in the lab, and
has a high quality genome assembly and tractable genetic manipulation with CRISPR-Cas9. In the proposed
work, we build on recent work showing that this species shows evidence of several shifts in ecology across
sharp spatial clines, and across decades and even seasons in its native range in Africa to characterize the
genomic basis of these rapid and repeated shifts in ecology. We will use field study of rapid fluctuations in
genome-wide allele frequencies across the starkly different dry and wet seasons of the southern edge of the
Sahel in Senegal to characterize the genome-wide distribution of adaptive variation and patterns of selection
across the genome. We will couple this with high-resolution mapping of genes involved in key putatively
adaptive traits in the lab, and functional characterization of these genes using reciprocal hemizygosity tests in
hybrids between human-specialist and generalist lab strains. We will take advantage of this species’ short
generation time to carry out experimental evolution studies of the role of genomic architecture in rapid
evolution – in particular, we will examine the role of a recently characterized large chromosomal inversion in
mediating rapid ecological transitions in space and time. The proposed work will synthesize direct observations
of allele frequency change in nature and focused laboratory study to come to a new and deeper understanding
of the genomic mechanisms that can enable rapid evolution.

Public health relevance
PROJECT NARRATIVE Evolution can drive profound change over millions of years, enabling species to inhabit entirely distinct ecological niches from their ancestors – but recent results suggest that ecological adaptation can occur much faster in some cases, across years or even seasons. The proposed research uses repeated transitions between human-specialist and generalist ecology in the mosquito Aedes aegypti as a model to ask just how fast ecological differences can evolve, and how. This work uses an integrative combination of field-based evolutionary genomics, CRISPR-Cas9 analysis of gene function, and experimental evolution to determine the genomic basis of ecological adaptation, and to analyze the ways that spatial patterns of standing genetic variation as well as the genomic distribution and effect sizes of adaptive loci shape the rapid evolution of ecological differences.